BLR&D Research Career Scientist Renewal Award Application

Dr. Riscoe’s Experimental Chemotherapy laboratory focuses on the discovery, optimization and translational
development of antiparasitic drugs, especially drugs for treatment and prevention of malaria, a severe and
potentially fatal tropical disease. Using modern methods of drug design and chemical synthesis his laboratory
has successfully created 5 novel antimalarial “chemotypes” with exemplary molecules in each category that are
orally bioavailable and curative in mouse models of infection. The Portland VA and neighboring OHSU have filed
for patent protection on all 5 chemotypes which include: 1) Dual functional acridones with blood stage activity
that interact synergistically with many standard antimalarial agents, 2) 4-­Aminoquinoline derivatives
(“Pharmachins”), designed to replace chloroquine, that are rapidly active against multidrug resistant strains of
Plasmodium falciparum parasites, 3) Quinolones (i.e., ELQ-­300) that block parasite mitochondrial respiration
and act vs. the blood, liver, gametocyte, and vector stages of parasite development, 4) Prodrugs of ELQ-­300 for
improved oral delivery and for injectable sustained-­release and long-­term protection against malaria, and 5)
Biguanides with enhanced synergy in combination with anti-­respiratory antimalarial drugs such as atovaquone
and ELQ-­300.
It is noteworthy that ELQs (e.g., ELQ-­316) are also potent against other parasites including Toxoplasma
gondii and Babesia microti with proven activity demonstrated in vitro as well as in vivo. T. gondii is a eukaryotic
intracellular parasite estimated to have infected billions of people worldwide, placing them at risk for
toxoplasmosis. Fetuses and immune-­compromised persons (e.g., HIV patients, transplant patients, and
individuals undergoing cancer chemotherapy) are susceptible to severe toxoplasmosis, which can be fatal or
lead to permanent ocular or neurologic disability. Even healthy people without immunodeficiency are susceptible
to ocular disease which may cause vision loss. B. microti causes babesiosis which is transmitted by ticks. It is
endemic in the New England region of the United States where it is called, “Nantucket Fever”. Like malaria and
toxoplasmosis, babesiosis is a potentially fatal infection and new and effective drugs are urgently needed. It is
noteworthy that B. microti is a common co-­infection associated with Lyme disease and is regarded as the
foremost infectious risk to the U.S. blood supply.
The Portland VA’s Experimental Chemotherapy Lab also investigates drug mechanism of action by use of
methods that are traditional to the fields of biochemistry, chemical biology and molecular parasitology. Dr.
Riscoe’s laboratory receives support from the Department of Veterans Affairs, National Institutes of Health, and
the Medicines for Malaria Venture and he maintains an active collaboration with members of the Division of
Experimental Therapeutics at the Walter Reed Army Institute for Research. He continues to serve as an invited
reviewer for the US DOD’s Peer Reviewed Medical Research Program (PRMRP) and the NIH. The long-­term
objective of Dr. Riscoe’s malaria research is to develop drugs that are inexpensive, safe and effective in
prevention and treatment of the most vulnerable populations, young children and pregnant women, and
ultimately to develop a cocktail of drugs that may be used to eradicate the disease.

Public health relevance
U.S. servicemen and women encountered malaria during the Revolutionary War and every US war since that time. Malaria and antimalarials are two of the most common biological and chemical exposures of US veterans. Multidrug resistant parasites have spread to virtually all malarious regions of the world. New drug strategies for prevention and treatment of malaria are urgently needed. My lab is committed to the development of safe and effective drugs that can be used in all individuals, regardless of their station: children, adults, men, women, pregnant, unborn, or genetically deficient in the enzyme glucose 6- phosphate dehydrogenase (G6PD). The resultant advantages of avoiding drug toxicity, febrile illness and complex medical management during deployment are self- evident, as are the benefits to both short and long- term health of the soldier.